OBSERVATIONS ON GLOBAL CEREBRAL ISCHEMIA IN RATS

These studies revealed most early and widespread reaction of GABAergic system following cardiac arrest cerebral ischemia. The damage of reticularis thalami was moderate in the inferior colliculus, whereas GABAergic system following cardiac arrest cerebral ischemia was not. The damage of GABAergic neurons was most pronounced in the nucleus reticularis thalami, moderate in the inferior colliculus, whereas GABAergic neurons in other locations showed recovery.